Effect of tumor editing on antitumor immunity

Project Summary
Immunotherapy has revolutionized cancer therapy, but most solid cancers do not respond. Thus, immunotherapy
needs to be improved. Developing cancers undergo tumor editing to evade immune surveillance. Because most
editing occurs before cancers are detected, surprisingly little is known about what genes are edited. Studies of
immune editing have examined candidate genes in antigen processing and presentation but have largely ignored
genes active in innate immunity, which plays a critical role in self:non-self or normal cell:tumor discrimination and
in inducing and amplifying adaptive immunity. Genome-wide studies of tumor immune editing have not previously
been done. Our first goal is to identify genome-wide changes in gene expression early in tumorigenesis in a
variety of cancers by taking advantage of genetically engineered mouse models (GEMM) of cancer to capture
and compare early vs late spontaneously arising tumors, using scRNA-seq, spatial transcriptomics and
multiplexed flow cytometry and immunofluorescence microscopy to identify the genes/pathways whose
expression is suppressed during early tumorigenesis. We will also identify changes in gene expression in the
tumor and metastatic niche in the transition from dormancy at tissue sites of colonization to macrometastases.
Comparing both tumor and infiltrating immune cell gene expression, cell subset abundance, cell-cell
communications and spatial organization will provide a detailed picture of how tumor editing leads to immune
exhaustion and evasion of immune surveillance and identify the genes, pathways, and processes that are
suppressed. Preliminary data suggest that early tumor editing is highly focused on genes involved in both
adaptive and innate immunity, including interferon, inflammasome/pyroptosis, necroptosis, and inflammatory
cytokine pathways, which are epigenetically repressed. The dominant genes/pathways edited in GEMM will also
be examined in human cancers, comparing gene expression and immune cell infiltration in carcinoma in situ with
advanced carcinomas. Reversing immune editing could potentially convert immunologically cold tumors into
immune responsive tumors. Epigenetic repression of gene expression by DNA hypermethylation of promoters is
a major mechanism of gene repression that is prominent during tumor editing. Our next goal is to determine how
much DNA hypermethylation and other epigenetic changes contributes to tumor editing and whether inhibiting
DNA methylation or other epigenetic modifications that maintain heterochromatin can reignite protective
immunity or induce responsiveness to checkpoint inhibition. Another goal is to investigate in more detail the role
of suppression of specific innate immune pathways in the tumor and in specific immune cell subtypes in tumor
resistance to immune control. We will determine whether activating specific innate immune pathways, repressed
during tumor editing, using small molecule activators or inhibitors or tumor-targeted RNA-based gene
knockdown, knockout or mRNA expression, can induce immune responsiveness in immunologically cold tumors.
These studies will identify novel drug targets that could potentially reverse editing and restore tumor immunity.

Public health relevance
Project Narrative This project will identify without bias the genes and pathways that are repressed during the development of 1o tumors and metastases in genetically engineered mouse models of solid cancer that enable tumors to evade immune surveillance. It will investigate tumor genes that stimulate innate immunity and ways to induce their gene expression or activate them to enhance immune recognition and control of tumors to reverse immune evasion and increase immune surveillance and responsiveness to checkpoint blockade. The identification of novel drug targets and therapeutic approaches will point the way for developing therapeutics that could enhance the range of solid tumors effectively treated with immunotherapy.